The immune regulation of macrophage antibody dependent cellular phagocytosis

Project Summary
The killing of target cells by therapeutic antibodies is expanding the effective treatment options for a wide
range of autoimmune diseases and cancers. Mounting evidence from mouse models, humanized mouse
systems and the analysis of human tissues, indicates that macrophages are principal effectors of therapeutic
antibodies, mediating the destruction of infected, malignant and immunologically aberrant cells. Fcγ receptors
(FcR) on the surface of macrophages bind target-cell associated monoclonal IgG class antibodies (mAbs) to
initiate antibody-dependent cellular phagocytosis (ADCP) and killing of the target cell. Patient responses to
mAb therapies can vary from complete remission to minimal therapeutic effect. One poorly explored possibility
is that the variability of the ADCP response is its dependence on macrophage polarization under the influence
of immune modulation. Specifically, immunosuppressive environments alter macrophage polarization leading
to ineffective ADCP. Conversely, stimulators of interferon genes agonists (STINGa), acting through type 1
interferons (IFN-1) can dramatically potentiate ADCP and overcome immunosuppression.
Our overarching goal is to elucidate the mechanistic pathways by which macrophage activation controls FcR
function and ADCP using a systems biology approach across in vivo transcriptomics and whole genome
CRISPR screens. Identified gene-function relationships for ADCP will be validated in a novel vivo model and
translated to human macrophages and therapeutic antibodies. We hypothesize that ADCP is regulated across
major axes of macrophage polarization (M0, M1(IFNγ/LPS), M(IFN-1/STING), M2(IL4/13) and M(S)) by
gene-expression changes of yet undefined genes that modulate the A:I ratios of FcRs, their signaling machinery
and innate cellular recognition receptors. Our proposal has two innovative aims that will vastly expand
understanding of the regulation FcR-dependent ADCP. In Aim 1, we will elucidate the macrophage genes
contributing to differential FcR function and ADCP across M1, M(IFN-1/STING), M2 and M(S). This aim takes
advantage of a new CRISPR-based whole genome screening strategy to identify genes that promote and inhibit
ADCP in primary derived macrophages. Aim 2 will delineate macrophage gene regulation supporting FcR
function and ADCP in vivo. Here we will translate findings from patient data and the CRISPR screen from Aim
1 to define regulators of ADCP in vivo. Both aims will focus on clinically relevant anti-B cell (Rituximab) and
anti-T cell (CAMPATH) antibodies, and will generate findings that extend our understanding of Fc-dependent
killing mechanism of ADCP.

Public health relevance
Project Narrative The proposed project is relevant for public health because therapeutic antibodies are one of the most promising class of drugs for treatment of autoimmune diseases, infections, cancers and modulation of immune function. This work is relevant to the mission of NIH in that it will advance the critically needed understanding of how therapeutic antibodies function thereby providing new guiding principles for therapeutic design.